7T Vascular and Molecular Imaging of SVD: Sex, Equol, and Risk of Alzheimer’s Disease

ABSTRACT
Mixed pathologies of cerebral small vessel disease (SVD) and Alzheimer’s disease (AD) represent the most
common cause of dementia in the elderly population. The presence of SVD exacerbates the progression of
AD. Multiple sex-specific AD risk factors contribute to a heightened SVD-related AD risk in women. With its
potent estrogenic, antioxidant, and anti-inflammatory effects, Equol has beneficial effects on cerebral blood
vessels. Therefore, leveraging the ongoing NIA-funded multi-site "Arterial Stiffness, Cognition, and Equol
(ACE)” trial, the proposed 7T-ACE study aims to characterize sex differences in cerebrovascular aging and
associated neurochemical substrates (Aim 1) and to determine the role of Equol in improving cerebrovascular
health (Aim 2). The proposed 7T-ACE study takes advantage of ultra-high field 7T vascular and molecular
imaging to assess cerebrovascular aging and associated neurochemical changes. Our 7T vascular imaging
characterizes blood-brain barrier (BBB) function, small vessel morphology, white matter microstructure, and
white matter hyperintensities (WMH). Specifically, with advances in 7T time-of-flight MR angiography (TOF-
MRA) and susceptibility weighted imaging (SWI) and with our newly developed and validated VesselMapper
and BrainVein methods, we are able to characterize the morphological features of small arteries and small
veins. Our 7T molecular MR imaging using the state-of-the-art whole-brain magnetic resonance
spectroscopic imaging (MRSI) measures brain metabolites associated with cerebrovascular aging, including N-
acetylaspartate (NAA) and glutamate (Glu) (markers of neuronal integrity) and myo-inositol (mI) (a marker of
glial cells and inflammation). Compared to WMH (a conventional marker of SVD), these novel morphological
and molecular markers reflect specific, early, mild, and reversible damage and thus are particularly important
in developing therapeutic targets for disease prevention and treatment. Recently, brain age (BA) models have
been developed using machine learning algorithms to predict age from T1-weighted MR images. These
models primarily fit gray matter atrophy patterns (referred to as GM-BA) and lack discrimination regarding
white matter, where vascular changes are prominent. Using these GM-BA models, women are consistently
found to be 1.5-3.5 years younger than men. This obviously does not align with the epidemiologic findings that
women are disproportionately affected by AD, suggesting that GM-BA models alone are not sufficient to
characterize brain aging. Therefore, besides GM-BA models, a white matter brain age (WM-BA) model trained
with WM microstructural features is proposed in this study to characterize cerebral white matter aging process.
The proposed 7T-ACE study will characterize effects of sex and Equol treatment on cerebrovascular aging and
associated neurochemical profiles. The proposed study will also identify primary factors contributing to these
effects. Understanding sex- and Equol-related effects on cerebrovascular aging and cognition will guide a sex-
specific precision treatment strategy in AD prevention.

Public health relevance
Project Narrative Co-occurring small vessel disease (SVD) in the brain accelerates the progression of Alzheimer’s disease (AD). Older women have a greater SVD-related AD risk. In this study, using state-of-the-art MR imaging, we will test whether women have faster progression of SVD than men. We also evaluate the treatment effects of Equol, an oral supplement, on brain SVD. Targeting SVD with an intervention is particularly promising for reducing AD risk in women.